Development and Feasibility Testing of novel icephobic Surface Technology for Mitigating Safety Risks of Commercial Fishing Vessels

Project Summary/Abstract
This project will develop a novel deicing technology for commercial fishing vessels operating in
cold regions to mitigate the safety risks associated with various icing effects such as ice accretion,
frozen latches, slippery deck areas, walkways, or ladders, which could cause slips, falls, or
significant changes to the vessel’s stability. Based on more than ten years of research conducted
by the project team, this new technology uses nanostructured icephobic surface treatments and
will be adapted specially for its application to commercial fishing vessels, such as its durability
and costs. The anti-icing performance will be tested and verified in a world-unique testing facility
with well controlled ambient conditions. The laboratory-verified surface materials will be produced
for a field trial on a commercial fishing vessel going for fishing activities in the winter. The surface
materials will be evaluated at different locations onboard by comparing their anti-icing
performances with those of the associated control areas.
The project team will document the methodologies and results of the research in an ABS
publication specific for the commercial fishing industry. The publication will stimulate interest of
the industry in accepting effective deicing technologies as a future safety feature of commercial
fishing vessels. The publication will also invite further discussions on the improvement of the
icephobic surface technology developed in the present project.

Public health relevance
PROJECT NARRATIVE This project will focus on development and testing of novel icephobic surface materials to be applied to commercial fishing vessels. The novel, nanostructured surface materials to be developed, along with their implementation methods, aim to help eliminate, mitigate, or control the ice accretion onboard commercial fishing vessels operating in cold regions. With alleviated icing effects, the associated risks such as loss of vessel stability or injuries of the crew members can be reduced. The design and fabrication of the icephobic surface technology is based on the best science available to date and will be adapted particularly for the hazards threatening small and medium sized commercial fishing vessels operating under severe weather conditions. The completion of the project will provide an effective deicing/anti-icing technology for the commercial fishing industry and will build a solid basis for follow-up research in improving commercial fishing vessel survivability and crew safety under icing conditions.